Deep Learning to Improve Interpretation of Intrapartum Fetal Monitoring

PROJECT SUMMARY
Electronic fetal monitoring (EFM) is used in greater than 85% of births in the United States, with the goal of
allowing clinicians to detect changes in the fetal heart rate that may indicate fetal academia, enabling them to
intervene prior to irreversible fetal injury. EFM was disseminated into practice prior to robust assessment of its
efficacy, and decades of work since have shown that EFM is limited in achieving its intended goal of preventing
intrapartum hypoxic-ischemic injury, and is associated with a significant increase in obstetric intervention,
especially cesarean delivery. Much work has been done to develop guidelines and standardized frameworks
for EFM interpretation in the hopes of improving both neonatal outcomes and the precision of obstetric
interventions, but nearly 175,000 cesarean deliveries continue to be performed unnecessarily in the US
annually due to false-positive interpretations of EFM.
In response to many of these challenges, computerized interpretation of EFM has been explored since
the 1980s. Unfortunately, the existing software programs, which are largely designed to detect the same EFM
features that clinicians do, have not demonstrated clinical benefit in randomized controlled trials. In answer, our
group hypothesized that a novel, data-driven deep learning approach could potentially detect meaningful data
patterns in EFM, beyond those features that clinicians or other software programs recognize, that could help
improve the predictive accuracy of EFM. Accordingly, we developed a deep-learning model that uses EFM
data to predict fetal acidemia. The best performing model achieved an AUROC of 0.85 at an umbilical cord
gas pH threshold of <7.05. These initial results provide proof-of-concept that a purely data-driven model can
achieve promising predictive performance. Given this exciting start, we are now seeking to further validate
and refine this model, and assess its potential role in clinical care. Accordingly, we propose to 1) Improve
and refine our preliminary AI-EFM model by leveraging large, diverse datasets 2) compare the performance of
the model to clinical interpretation (gold standard) and 3) assess the acceptability and perceived barriers to use
of such a model in intrapartum patient care by conducting qualitative interviews with clinicians. The completion
of this proposal and each of these aims are essential next steps in moving this innovative technology towards
impactful clinical application and future evaluation in a randomized controlled trial. This work has the potential
to enhance the accurate detection of true fetal distress warranting obstetric intervention, while also reducing
the subjectivity and cognitive biases in interpretation of EFM. If rigorously tested and prudently deployed, this
technology has the potential to improve outcomes for millions of birthing patients and neonates.

Public health relevance
PROJECT NARRATIVE Electronic fetal monitoring (EFM), while ubiquitous, is limited in achieving its intended goal of preventing fetal intrapartum injury, and false-positive interpretations of fetal distress on EFM lead to nearly 175,000 unnecessary cesarean deliveries annually in the United States alone. We have developed a novel deep- learning model that uses EFM data to accurately predict intrapartum fetal acidemia, and have shown that this model outperforms clinicians. Now, we are seeking to further validate and refine this model, more broadly and rigorously compare it to the performance of clinicians in identifying true fetal distress, and understand diverse clinician attitudes to the potential future role of this impactful technology in clinical care.